Streamlined Treatment and Evidence-based Adolescent counseling and Medication Support (STREAMS)

STREAMS Abstract
Interventions that use a combination approach—as recommended by UNAIDS—to address mental health in
low- and middle-income countries (LMICs), are crucial to achieving the UNAIDS 95-95-95 targets, yet few such
evidence-based combination interventions currently exist for the 1.7 million adolescents living with HIV
(ALWHIV) in Africa. We propose Streamlined Treatment and Evidence-based Adolescent counseling and
Medication Support (STREAMS) to evaluate a combination intervention comprising of streamlined interpersonal
psychotherapy groups (IPT-G) tailored to adolescents (15-19 years) and streamlined family strengthening and
treatment adherence counseling in rural Uganda. In our pilot work, PI Kreniske (K01MH122319) collaborated
with StrongMinds and Brown School’s International Center for Child Health and Development (ICHAD) to
demonstrate feasibility and acceptability of a streamlined text message based PHQ-9 screener to assess
depression. Adolescents were successfully linked to StrongMinds 6-week IPT-G counseling and experienced a
reduction in depressive symptoms. StrongMinds IPT-G counseling is tailored to the Ugandan context and has
been reduced from a program based on 16 IPT-G sessions to the streamlined 6 sessions. To date, this approach
has not been evaluated among ALWHIV. To address HIV counseling and adherence, we propose streamlining
Suubi+Adherence (R01HD074949; PI Ssewamala), a family-based combination intervention combining
economic empowerment intervention with medication adherence counseling for ALWHIV in Uganda that
improves antiretroviral (ART) treatment adherence but has not been examined specifically among youth
experiencing symptoms of depression. STREAMS will be implemented across 24 ICHAD-affiliated HIV health
clinics within the greater Masaka region of Uganda—a region heavily impacted by HIV compared to national
averages. We will use a Type I Hybrid design 3-arm cluster-randomized trial
to evaluate effectiveness
at both
reducing depressive symptoms and improving ART adherence, with the secondary aim of characterizing the
combined interventions’ feasibility and acceptability comparing (1) streamlined IPT-G and streamlined
Suubi+Adherence in combination, (2) streamlined IPT-G and SOC ART counseling (3) SOC mental health and
SOC ART counseling. Randomized at the clinic level, adolescents will be consecutively sampled, and those who
screen positive for depressive symptoms on the mobile phone administered PHQ-9 will be enrolled. Using
Consolidated Framework for Implementation Research (CFIR) informed in-depth interviews and analysis, we will
systematically assess barriers and facilitators to accessing mental health care and adhering to ART across CFIR
domains (e.g., individual characteristics, inner – healthcare settings) to inform scalable changes to care to
support HIV treatment among ALWHIV in rural Uganda. STREAMS examines if our mobile phone screening tool
along with a combination of streamlined StrongMinds IPT-G and streamlined Suubi+Adherence ART counseling,
provides a low-cost, efficacious, and scalable approach for improving mental health and ART adherence.

Public health relevance
STREAMS Project Narrative Combination interventions to address mental health and adherence to HIV care in low- and middle-income countries (LMICs), are crucial to achieving the UNAIDS 95-95-95 targets as one in four adolescents living with HIV (ALWHIV) experience poor mental health and this contributes to suboptimal medication adherence and lack of viral suppression. Yet few evidence-based mental health and adherence interventions have been evaluated in sub–Saharan Africa (SSA), the region where the majority of the 1.7 million ALWHIV reside. STREAMS will determine if our streamlined combination intervention approach to mental health screening, provision of evidence-based interpersonal psychotherapy groups (IPT-G), and evidence-based family strengthening, and medication counseling is feasible and efficacious for ALWHIV in Uganda.